Pilot Project Program

PILOT PROJECTS: ABSTRACT
The Pilot Project Program is a key component of the Center of Excellence in Environmental
Toxicology (CEET) that builds capacity in environmental health sciences (EHS). The Pilot Project
Program serves to support Early-Stage Investigators (ESI) that are interested in pursuing EHS,
and senior investigators who may be embarking on EHS projects for the first time. To assist in
the pilot project application process, we run a grant writing program within the Career
Development Program of the Administrative Core. The Pilot Project award opportunities fall into
four categories: (a) Mentored Scientist Transition Award (MSTA) which is our primary mechanism
of funding ESI (new recruits, clinician scientists, research track faculty) who need protected time
through salary support to establish their independent research programs; (b) an Opportunity
Award open to all junior and senior faculty who propose an innovative EHS or Implementation
Science project which is not ready for federal funding; (c) a “Rapid Response” award to promote
community-engaged research or provide funds to a faculty member who urgently needs to
generate preliminary data for an EHS relevant grant application; and (d) a Focused Research
Award to support research in the thematic areas of the Center: Air Pollution & Lung Health,
Environmental Exposures & Cancer, Windows-of-Susceptibility and Environmental Neuroscience
and cross-cutting themes in exposomics and the effects of extreme weather on health, and
support research that may lead to multi-investigator grant applications. Applications receive high
priority if they are likely to lead to extramural funding from NIEHS or respond to a RFA on which
NIEHS is a sponsor; and if they use one or more facility cores: the Translational Research Support
Core (TRSC), the Biomolecular Mass Spectrometry Core (BMSC), or the Environmental Health
Informatics Core (EHIC). Pilot projects are reviewed by expert faculty in the area of study and
recommendations for funding are made to the Executive Committee for a final decision. At the
end of the funding period, pilot project awardees are invited to present on their progress in the
CEET seminar series. Outcome metrics such as grant applications submitted, grants awarded,
and publications are updated on an annual basis to account for the significant lag phase that can
exist between the pilot project award and these successful outcomes.